The Impact of Biological Mechanisms of Aging on Response Variability to Resistance Training in Older Adults (BRIO)

SUMMARY
In most individuals, exercise counters the onset and progression of chronic diseases (e.g., type 2 diabetes,
cardiovascular disease, cognitive decline, and cancers), geriatric syndromes (e.g., frailty), and disability, even
when introduced in later-life. However, the physiological effects conveyed by exercise are highly variable across
individuals. In line with RFA-AG-24-045, this application builds on a robust scientific foundation and will use
innovative, multidisciplinary approaches to critically test the central hypothesis that biological mechanisms of
aging are modulators of exercise response heterogeneity (ERH) in older adults. Our proposal centers on cellular
senescence and epigenetics as causes of ERH in two distinct, clinically meaningful co-primary outcomes:
physical function and insulin sensitivity. Senescence is a cell fate that contributes to age-related tissue pathology
and impairs regeneration. Recently, we characterized hallmarks of cellular senescence in human skeletal muscle
and observed negative associations with measures of physical function and insulin sensitivity. We have also
demonstrated that circulating biomarkers of cellular senescence are associated with deficits in physical function
and are responsive to exercise training. Epigenetic modifications effectively govern transcriptional programs that
regulate cellular homeostasis and adaptations to stimuli. DNA methylation (DNAm) at CpG sites is a key
epigenetic modification that changes radically with advancing age. In skeletal muscle, age-associated alterations
in DNAm affect the expression of genes central to functional and metabolic adaptations to exercise. Based on
these observations, we will conduct a randomized, two-site clinical trial of a 6-month structured progressive
resistance training intervention (n = 200) and a health education intervention (HE) (n = 100) to define the ERH
in physical function (Specific Aim 1) and insulin sensitivity (Specific Aim 2) in community dwelling older (³ 65
years) women and men with evidence of mobility limitations. We will use state-of-the-art molecular profiling to
rigorously examine cellular senescence and DNAm in skeletal muscle in parallel with their blood-based
biomarkers. Through predictive approaches to treatment effect heterogeneity, we will examine how these
biological mechanisms, key clinical variables (sex, BMI, comorbid conditions, medications, depression, and
fatigue), and behavioral factors (nutrition, habitual physical activity, sleep, fatigue, and depressive symptoms),
and their interactions, mediate ERH.

Public health relevance
NARRATIVE In this proposal, our overall goal is to examine how two biological processes involved in aging and age-related conditions, cellular senescence and epigenetic alterations, influence adaptations to exercise training in older adults. We will conduct a randomized controlled clinical trial comparing the effects of 6-months of strength training to a health education program on measures of physical function and whole-body metabolism in persons 65 years of age and older. Using risk modeling approaches, we examine how the biological processes, clinical variables (e.g., sex, chronic conditions, medications), and behaviors (e.g., nutrition and sleep), and their interactions, influence changes in these clinically important outcomes in study participants.